Role of Natural Antibodies and B1 cells in Fibroproliferative Lung Disease

PROJECT SUMMARY
Idiopathic pulmonary fibrosis (IPF) is an interstitial lung disease (ILD) of progressive scarring and no cure.
Current pharmacologic interventions in IPF target canonical myofibroblast signaling, but at best slow disease
progression, and median survival post diagnosis is 3-5 years. Dysregulated immunity of myeloid and lymphoid
populations is party to the progression of fibrotic disease. Lung B cell frequency increases in human ILDs, and
in both sterile and infectious animal models of fibroproliferative lung injury. The appearance of B cells in the
alveolar spaces, a phenomena absent in healthy tissue, is characterized by both single lymphocytes and in
larger, organized accumulations of lymphocytes termed tertiary lymphoid organs (TLOs). Our preliminary data
show natural B cell immunity is protective in lung injury. Natural immunity is mediated B-1 cells, a type of T-cell
independent B cell which produces natural antibodies (nAb). These nAb are largely IgM, and are protective in
inflammatory and fibrotic pathologies. B-1 cells primarily reside in the serosal cavities, including millions of B-1
cells in close contact with the lung in the pleural cavity. We believe these pleural B-1 cells are a reservoir of
nAb producing cells which are highly responsive to changes in soluble factor signaling from the lung.
In supporting data for this proposal, we have found that increases in a B-1 secreted species of nAb against
oxidized lipid is protective against bleomycin-induced lung injury in mice. The increase in lung B-1 cells and
nAb after lung injury occurs concomitant with changes in chemokine receptor (CR) expression in the pleural B-
1 cell compartment.
Our central hypothesis is that pleural B-1 cells traffic to the lung in a CR-dependent manner and
protect from fibroproliferative injury via production of nAb. Our overarching goal is to understand the
pleural B-1 cell response to lung injury, and elucidate the mechanisms by which nAb is protective in disease.
To this end, we propose to test following aims: First, test the hypothesis that pleural B-1 cells traffic to the lung
during lung injury in a CR-dependent manner. Second, test the hypothesis that secretion of nAb by B-1 cells is
protective in fibrotic lung injury. These experiments will make use of extant transgenic mouse lines and
established mechanistic approaches both in vivo and in vitro to dissect the B cell-Fibrosis axis in lung injury. It
is novel in that it will answer mechanistic questions relating natural immunity in fibrosis, and identify
new and potentially targetable signaling pathways in fibroproliferative disease – vital for the
development of better treatments. The environment in which I will perform the proposed work could not be
better suited; the University of Virginia is a world-class research university and we have assembled a world-
class team to support this endeavor through intentional planning for both science and personal/professional
development.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is an interstitial lung disease (ILD) of progressive scarring and no cure. The appearance of B cells in the alveolar spaces and heightened presence of natural antibody (nAb), a protective immunoglobulin, indicate a pronounced change in the activity of B cells in disease. The mechanisms by which these B cells and nAb are recruited, and their impact on the fibrotic process, is unknown and is the focus of this application.